Predoctoral Training Program in Signaling and Cellular Regulation

SUMMARY
The goal of this training grant proposal is to prepare predoctoral trainees for productive research
careers in the field of signaling and cellular regulation. The training faculty mentors consist of an
outstanding, internationally recognized group of researchers in the Department of Biochemistry
and the Department of Molecular, Cellular and Developmental Biology, who, by using the
highest standards of scientific rigor and reproducibility, have make major breakthroughs towards
the discovery and characterization of new mechanisms for biological cell signaling and
regulation. The program will mentor students to gain critical thinking skills and depth in
understanding how to assimilate different scientific areas to solve problems in modern molecular
biosciences, and teach them how to use apply these skills when they enter the biomedical
research workforce. Program elements will include program-specific elective courses, an annual
Symposium, Supergroup research conferences, seminars, and journal clubs, together with
trainee monitoring through thesis committees and organizational meetings. These approaches
will expose students to broad, interdisciplinary scientific areas through cross-disciplinary
mentorship, collaboration, and team building; provide them with rigorous training in experimental
design, classical and modern technologies, and data analysis, with high standards for
reproducibility; foster a proactive community effort to promote the recruitment and retention of
underrepresented trainees; and support students’ progress and ability to work in teams in an
inclusive environment through all aspects of their training. Coursework on responsible conduct
of research will instill students with an awareness of norms and expectations for conducting
research with high ethical standards. Professional development and career training workshops
will expose students to diverse career trajectories and opportunities, with experiential coaching
for planning and landing employment. By integrating SCR Program-specific coursework and
activities with departmental graduate program requirements, and through mindful and
responsive mentoring, we will create a thriving collaborative, inclusive, and interdisciplinary
graduate training environment.

Public health relevance
NARRATIVE The goal of this training grant is to prepare the next generation of scientists who will conduct high quality research leading to new discoveries in biomedicine. The research focus of students who train in our program is to understand fundamental mechanisms in signaling and cellular regulation, an area which is key to the discovery of new therapeutic treatments for human diseases such as cancer, diabetes, inflammation, heart disease, immunological and neurological disorders, and birth defects, and forms the foundation for modern research in biology and medicine.